General Purpose Brain-Computer Interface (BCI) System

DESCRIPTION (provided by applicant): Signals from the brain can provide non-muscular communication and control channels, or brain-computer interfaces (BCIs), to people with amyotrophic lateral sclerosis (ALS), brainstem stroke, cerebral palsy, or spinal cord injury. BCIs can allow people who are severely paralyzed, or even locked in, to use brain signals to write, communicate with others, control their environments, access the Internet, or operate neuroprostheses. The realization of clinically useful BCI systems requires work in three areas: (1) acquisition of brain signals; (2) signal processing; and (3) clinical implementation. Because these areas involve very different disciplines, research groups usually focus on only one area. Thus, at the beginning of this BRP, despite the exciting achievements of researchers around the world, the field had progressed only to the point of laboratory demonstrations, in large part because achievements in one area were not integrated with those in others. In the past grant period, this BRP changed that landscape. First, it developed and disseminated to more than 160 research groups a general-purpose BCI software platform, called BCI2000, that facilitates all aspects of interdisciplinary BCI research and development, from laboratory to home. Furthermore, it used BCI2000 to develop the first BCI system designed for independent home use, and successfully tested this prototype in long-term home use by a small group of people severely disabled by ALS. Building on this work, the goal of this renewal proposal is to establish the first vertically-integrated BCI research and development program, and use it to produce BCI systems that are fully practical for independent use in clinical and home settings. The proposed program extends from signal acquisition, to signal processing, to application development and clinical implementation. By including and coordinating the activities and achievements in these different areas, this program will create and validate the first BCI systems suitable for widespread independent use by people with severe motor disabilities. Each BRP partner is in the forefront of one or more of the essential research areas, from hardware design to clinical testing. In limited ways, they already collaborate with one another. Working closely together and implementing new ideas, they will: (1) improve signal acquisition by developing more reliable, robust, and convenient chronic methods for recording electroencephalographic activity (EEG) and for exploring the BCI capabilities of electrocorticography (ECoG); (2) optimize adaptive feature extraction and translation algorithms for these signals; and (3) incorporate the results into BCI systems that are fully practical for home and clinical settings and establish the value of these systems for daily use by people with severe motor disabilities. By achieving these aims, disseminating the resulting technology, and providing other researchers access to its vertically-integrated framework, this BRP program should enable BCI research to produce BCIs that actually improve the lives of people with severe motor disabilities. PUBLIC HEALTH RELEVANCE Brain-computer interfaces (BCIs) can restore communication and control to people severely paralyzed or even locked-in by amyotrophic lateral sclerosis (ALS), brainstem stroke, cerebral palsy, or other devastating neuromuscular disorders. The goal of this Bioengineering Research Partnership proposal is to establish the first comprehensive BCI research and development program and use it to produce the first BCI systems suitable for widespread independent home use by people with severe motor disabilities.